Repeat associated neurodegeneration in CANVAS

Abstract:
Cerebellar ataxia with neuropathy and vestibular areflexia syndrome (CANVAS) is a late-onset, slowly
progressive and recessively inherited ataxia characterized by vestibular, cerebellar, and somatosensory
impairments and cerebellar degeneration that results in significant morbidity and early mortality. CANVAS is
caused by a biallelic, non-reference, pentameric AAGGG repeat expansion within the second intron of replication
factor complex subunit 1 (RFC1) gene in both familial and sporadic CANVAS, as well as a significant fraction of
all late-onset degenerative ataxias and sensory neuronopathies. Controls possess an average of 11 AAAAG
repeats at this locus, which is replaced with between 400-2000 AAGGG repeats in CANVAS patients. The
mechanism(s) by which this repeat expansion causes neurodegeneration are unknown. While CANVAS exhibits
a recessive pattern of inheritance, studies to date suggest that RFC1 expression is not impacted by the repeat
expansions. The expansion has the potential to be pathogenic within two different strand-specific contexts. On
the sense strand, the (AAGGG)n repeat sits within the poly(A) tail of an AluSx3 transposable element, while the
antisense strand (CCCTT)n repeat sits within the large second intronic region of RFC1. The goal of this
proposal is to define the mechanisms by which these repeat elements contribute to neurodegeneration
in CANVAS. To accomplish this, we will use a combination of patient-derived iPSC models alongside studies
using repeat-expressing reporters to investigate the expanded repeat within both its endogenous context as well
as within easily manipulable assay systems that will allow us to define the potential of these repeat elements to
elicit toxicity directly. Taken together, these studies will provide critical information needed to define the proximal
mechanism(s) and pathways that underlie neuronal toxicity and neurodegeneration within CANVAS – a critical
first step required for development of disease relevant therapeutics.

Public health relevance
Cerebellar ataxia with neuropathy and vestibular areflexia syndrome (CANVAS) is an inherited and highly debilitating ataxia caused by a repeat element in a gene encoding the replication factor complex subunit 1 (RFC1). In this study, we will test three possible mechanisms by which the repeat element might cause neurodegeneration: 1) through a loss of expression of some forms of RFC1 or neighboring genes; 2) through formation of repeat RNA-protein condensates; 3) through repeat associated non-AUG initiated translation of toxic pentameric peptides. It is hoped that this work will reveal key therapeutic targets in this currently untreatable human condition.